Opioid Use Disorder (OUD) Treatment and Harm Reduction Training Using AR (Augmented Reality) Technology

Over the last decade, drug overdose death has created an epidemic across the United States. In 2018,
there were 67,367 drug overdose deaths—a decrease of about 4.6% from 2017—but almost 70% of the deaths
involved opioids. While overdoses related to prescription opioids have decreased, synthetic opioids made up
over two-thirds of all opioid-related overdose deaths in 2018. West Virginia, Maryland, Pennsylvania, Ohio, and
New Hampshire had the highest rates of drug overdose deaths in 2018. Furthermore, there are reported
increases in overdose deaths that may result from isolation and access to drugs and treatment services related
to the COVID-19 pandemic. The goal of this proposal is closely aligned with the mission of the National Institute
on Drug Abuse (NIDA) to educate clinical providers and lay people on improving treatment and outcomes for
those suffering from substance use disorders (SUDs), specifically in response to drug overdose.
Many barriers have been identified for training providers on SUDs. Simulation-based training has shown
promise for training providers about responding to drug overdose during Basic Life Support (BLS) training.
However, simulation-based training is usually resource intensive and can be difficult to implement as current
simulator technologies require facilities, staff, and technology support.
Overdose education and naloxone distribution (OEND) is associated with improved outcomes for people
experiencing opioid overdose as well as decreased drug use by people who participated in OEND programs.
Increasing access to OEND could expand these positive results.
This Phase II SBIR aims to further develop Lumis’s Augmented Reality Training on Overdose (ART-OD)
within Lumis’s existing healthcare training simulator, the InSight Platform. The InSight Platform incorporates
knowledge-based and hands-on training, requires less resources than traditional simulation, and supports broad
deployment. The ART-OD prototype developed in Phase I met all benchmarks for success, including: (1)
development and integration of an ART-OD prototype into the InSight Platform, (2) increased knowledge and
attitudes towards recognizing and responding to an opioid overdose, and (3) positive feedback, usability, and
market acceptance from various stakeholders.
Mixed methods research will: (1) enhance the design of ART-OD developed in Phase I using an
expanded pool of subject matter experts (SMEs) and integration with an existing prototype for training clinicians
from the University of Florida College of Medicine (UCF COM), (2) integrating the enhanced design for ART-OD
and the UCF COM prototype into an advanced ART-OD product, and (3) conducting pilot testing of ART-OD with
potential end-users and stakeholders to validate training effectiveness and market potential.

Public health relevance
Overdose education and naloxone distribution (OEND) programs show promise towards reducing opioid-related overdose deaths as well as reducing drug use. While it is common for OEND programs to use patient simulators for hands-on training of cardiopulmonary resuscitation (CPR), most programs lack the capabilitites and resources for training hands-on administration of naloxone during complex overdose scenarios. The goal of this Phase II SBIR is to further develop Lumis’s Augmented Reality Training on Overdose (ART-OD) curriculum within Lumis’s immersive healthcare training simulator, the InSight Platform, for rapid training deployment to directly save lives.